Circadian Regulation of Antibiotic Resistance in the Microbiome

Project Summary
Humans must regulate a symbiotic relationship with almost 100 trillion intestinal bacteria which readily harbor
antibiotic resistance genes and the mechanisms that spread them. Despite the relentless rise of antibiotic
resistant infections little is known about the host factors that regulate antibiotic resistance development in vivo.
Preliminary investigations revealed that the mammalian circadian clock may be such a factor. Prior in vivo studies
have demonstrated that the circadian clock drives daily rhythms in microbiome composition which are
synchronized to the day-night cycle. However, gene expression in the microbiome at circadian time scales is
largely unexplored. To this end, a comprehensive study of the mouse microbiome was performed across the
day-night light cycle. These data revealed that beyond daily rhythms of microbe abundances, extensive
transcriptional rhythms occur in the microbiome across the day-night light cycle. Indeed, antibiotic resistance
and horizontal gene transfer systems showed some of the most significant transcriptional rhythms in the
microbiome, reaching peak expression within a 4-hour window each day. These preliminary data demonstrated
that transcription in the microbiome is temporally structured in vivo. These diurnal (daily) rhythms are
characteristic of regulation by the host’s circadian clock. Therefore, this proposal seeks to understand
mechanisms driving diurnal bacterial transcription in the microbiome by examining the in vivo regulation of
horizontal gene transfer and the impact of the host circadian clock on the spread of antibiotic resistance. Taken
together, this work proposes the circadian clock synchronizes transcription in the microbiome to the day-night
cycle, potentially revealing a mammalian regulator of antibiotic resistance development.

Public health relevance
Project Narrative Antibiotic resistant infections are a worldwide health crisis driven by the evolution and spread of antibiotic resistance genes within microbiomes, yet the factors that govern this in vivo are largely unexplored. The mammalian circadian clock controls predictable daily rhythms in microbiome composition which drives consequential rhythms in host physiology. This proposal follows extensive preliminary data that connects these processes and investigates how the mammalian circadian clock synchronizes antibiotic resistance mechanisms in the microbiome with the environmental day-night light cycle.